Ear Level Cooling for Otoprotection

ABSTRACT
We previously demonstrated significant protection from cisplatin induced hearing loss using cool water ear
canal irrigation. However, the study was limited to a single bolus injection of cisplatin and acute time period
(Spankovich et al. 2016). More recently, we examined application of localized cooling of the ear canal with
repeated doses of cisplatin, over an expanded period of time, and using an alternative method of cooling (ear
bar cooled by a Peltier device). Here, we propose to advance our novel application of localized ear cooling in
mitigation of drug induced hearing loss; which we call Cool OtOprotective ear Lumen (COOL) therapy.
Hypotheses: We hypothesize that (1) our COOL therapy will show protection in a rat model; (2) protection
from our COOL therapy is mediated by reduced cochlear uptake of cisplatin, expression or cold shock
proteins, and reduced upstream and downstream cell apoptotic cell death pathways; (3) that we will observe
protection from vestibular damage with our COOL therapy.
Specific Aims: Aim 1. To determine whether COOL therapy reduces cisplatin uptake and auditory-vestibular
pathology, increases the expression of transcripts that code for cold-shock proteins, and reduced cellular
stress pathways.
Study Design: For Aim 1, Guinea pig and Long Evans rats will be exposed to cisplatin while undergoing
COOL therapy and compared to sham controls and warmed animals. Aim 1(a) will determine if our findings
translate to another species (rat) and explore vestibular effects. Aim 1(b) will examine antibody
immunostaining for cisplatin DNA-adducts, mass spectrometry measured platinum concentrations in cochlear
tissue, and confocal images of animals treated with fluorescent tagged cisplatin. Aim 1(c,d) will examine
expression of cold shock proteins and evidence of lipid perioxidation and caspase-3 activation.

Public health relevance
PROJECT NARRATIVE We propose a series of experiments to examine a novel non-pharmacological method for otoprotection, localized ear cooling, we call Cool OtOprotective ear Lumen (COOL) therapy. Our proposed strategy is forward thinking with model designs based on consideration of clinical translation. Our COOL therapy may prove to be a stand-alone or adjunctive therapy with other otoprotective strategies for mitigation of drug induced hearing loss.